AIR POLLUTION ON BREATHING ASSESSED BY LUNG LAVAGE IN HEALTHY HUMANS

Nitrogen dioxide or sulfuric acid aerosol exposure will be followed by fiberoptic bronchoscopy to assess cellular and biochemical lung responses. Immediate and delayed responses are being evaluated. This is a CDMAS only protocol. The investigator will continuing using the data for analysis.